Administrative Core

The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) Administration serves as a centralized unit responsible for coordinating, facilitating, and supporting basic, clinical, and population sciences research, education and training, community outreach and engagement, and cancer clinical trials. Administration supports 193 faculty members in 4 Research Programs, and 10 Shared Resources with over $82M in cancer-relevant grants and 3,108 peer-reviewed publications. Administration oversees ~300 active trials at any time and our interventional (treatment and non-treatment) accruals grew from 5,786 to 6,644 (15% increase) during the grant period. Administration is responsible for planning, operationalizing, and monitoring these activities. Administration provides management and oversight of all activities that support the Director’s vision and the research of its members including, but not limited to: strategic planning and monitoring; management of Center finances; personnel; grants and contracts; purchasing; philanthropy; oversight of space utilization; facilitation of faculty recruitment efforts; oversight of Shared Resources; Pilot Project and Team Science Award solicitation, review, and funds allocation; improving clinical trials infrastructure; development of educational programs; coordination of Center meetings and inter- and intra-programmatic interactions; and communications with UCCCC members, the lay public, donors and other Cancer Centers. Key accomplishments of Administration over the current grant period have included: development of a new Strategic Plan; implementation of EVAL database to track membership, publications, and funding; revision of and implementation of an enhanced cancer relevance policy; facilitation of key programmatic and leadership recruits (45 new members from outside of the University of Chicago); development of team science working groups and submission of multi-investigator grants such as SPOREs and P01s (4 submissions and 1 resubmission in the past two years); organization of a clinical trials task force which led to significant reorganization and expansion of the infrastructure into the Clinical Trials Support Office; facilitated development of the Accelerator for Cancer Therapeutics initiative between UCCCC and Argonne National Laboratory; and planned and launched two developing shared resources, Organoid and Primary Culture Research Core and Cancer Metabolomics Platform. Over the next grant period, Administration will build on these efforts to implement the Strategic Plan and monitor its success; enhance the clinical trials infrastructure with continued investment in new technology; continue to expand leadership capacity through strategic recruitment; and enhance regionally focused research initiatives through partnerships that promote access to care and scientific collaboration.